Mechanisms and Impact of NRG3 Induction in Bone Metastasis

Without the occurrence of cancer cell dissemination (metastasis), most breast cancer patients would
survive following diagnosis and treatment. Alas, cancer cells can disseminate to distant sites long
before diagnosis of the primary tumor. Based on clinical investigations, bone is established as the most
predominant site of metastasis in breast cancer. Over the years, we started to realize a preferential
association of breast cancer subtypes with certain metastatic sites. For instance, hormone receptor-
positive (HR+) breast cancer, which represents the most common subtype of breast cancer (65-70%),
has a high propensity toward skeletal tissues compared to HR- subtypes (TNBC and HR-/Her2+).
Accumulating evidence indicates a key role of bone resident cells (osteoblasts, osteoclasts, and
vascular cells) in these processes. Although multiple mechanisms can contribute to these processes,
the clinical implications remain limited. Recently, we identified a bone-induced factor (NRG3) that may
help switch current paradigms. NRG3 is part of the neuregulin family of ligands that modulate erbb
receptors. While the role of Neuregulins is still enigmatic in breast cancer, our preliminary results
suggest strong implications in metastasis progression. Here, we will use molecular approaches to (i)
determine and functionally characterize the NRG3 regulome induced in the bone microenvironment, (ii)
identify the NRG3 signaling using genetic approaches, and (iii) assess the impact of NRG3 depletion
on secondary metastasis. Considering the well-established role of Receptor Tyrosine Kinases such as
Her2 in stemness, DTC, and metastasis progression, our proposed investigation may uncover novel
bone-mediated properties with high therapeutic potential.

Public health relevance
Despite the accumulating evidence supporting a key of bone in cancer progression and therapeutic resistance, the mechanisms driving secondary metastasis are superficially understood. Here, we propose to functionally and mechanistically investigate Neuregulin 3 (NRG3) in the process of metastasis expansion from bone to visceral organs.